Particle-induced Cardiopulmonary Injury In Mice: Genetic

Because of the impact that particle-gas exposures may have on public health, identification of host factors that influence susceptibility to airborne pollutants remains an important issue. Particular concern has arisen about potentially sensitive sub-groups such as children, asthmatics, and the elderly. Individuals with cardiopulmonary disease are at particular risk to the effects of exposure. Recent evidence has suggested that some individuals may be genetically predisposed to environmental stressors, including oxidants and particles. Epidemiological studies have also suggested that PM may produce significant changes in cardiovascular function in addition to its pulmonary effects. In ongoing studies, we have began to test the hypothesis that genetic background is an important host factor that contributes to interindividual responsivity to particulate-induced immune dysfunction (an indicator of morbidity) and decreased heart rate variability (HRV). We initially designed a study to identify susceptibility loci for alveolar macrophage (AM) immune dysfunction induced by inhalation of sulfate-associated carbon black (CB) particles in differentially susceptible B6 and C3 inbred mice. AMs were chosen for study because they represent in important component of host defense, and compromised host defense has been hypothesized to be an important factor in particle-induced respiratory morbidity. B6 and C3 mice were chosen for investigation because a strain screen identified them as the most differentially susceptible to CBA/SO2-induced phagocytic dysfunction among eight strains studied. A B6C3F2 cohort was genotyped at 147 SSLP markers and a QTL on chromosome 17 exceeded the threshold value for statistically significant linkage as determined empirically by permutation test. A QTL on chromosome 11 exceeded the threshold for suggestive linkage. Candidate susceptibility genes in the chromosome 17 QTL were identified by comparative mapping and included Tnf, Lta, and Ccl2 (monocyte chemoattractant protein 1). Importantly, both QTLs overlap previously identified susceptibility QTLs for lung injury induced by the common pollutant ozone, as well as bleomycin and radiation. This may suggest common regulatory loci for injury and inflammation in the lung. Because particulate air pollution has many sources and composition varies regionally, we have expanded our studies to include another particulate called ROFA (residual oil fly ash). ROFA is a particle pollutant derived as a combustion product of fuel oil. ROFA contains soluble sulfates and substantial levels (10% in mass) of soluble transition metals including iron (Fe), vanadium (V), and nickel (Ni). These three principal ROFA-associated metals have well-documented human health effects in respiratory airways. ROFA induces airway hyperreactivity and acute pulmonary injury characterized by neutrophilic inflammation, pulmonary hyperpermeability and edema, pulmonary fibrosis, and increased susceptibility to microbial infections. Although high content of transition metals are thought to account for the adverse pulmonary effects by generation of oxygen-based free radicals in the lung, the precise mechanisms through which ROFA induces lung injury and inflammation are not resolved.